Re-Engaging AYA Survivors in Cancer-Related Healthcare (REACH): A Sequential Multiple Assignment Randomized Trial (SMART)

PROJECT SUMMARY/ABSTRACT
Over 80% of children diagnosed with cancer become long-term survivors; however, 70% develop chronic or
life-threatening late effects from treatment, and these often emerge during young adulthood. Guidelines
recommend annual long-term follow-up care (LTFU) to manage and monitor for late effects, recurrence, or new
cancer(s). Yet, as risk for late effects increases in young adulthood and survivors transition into adult-focused
care, engagement in care plummets. Disengagement from LTFU leaves adolescent and young adult survivors
(AYA) vulnerable to delayed or poorly managed diagnoses, and relates to lower knowledge and self-
management abilities. Thus, interventions targeting re-engagement of AYA are critical for this vulnerable
population. In order to address this critical intervention need, we propose REACH (Re-Engaging AYA survivors
in Cancer-related Healthcare)—an innovative sequential multiple assignment randomized trial (SMART) with a
two-stage design. We will leverage our research on transition to adult care, survivorship care plans, and digital
health interventions. Stage 1 tests a low touch intervention (LTI), consisting of reminder “nudge” text messages
and informational resources for up to 4 weeks compared to an enhanced usual care group that will receive
written information (WI) only. Next, in Stage 2, AYA will be re-randomized based on responsiveness to Stage 1
(i.e., whether or not they made an appointment) into 16 weeks of intervention. Responders will either be re-
randomized to receive a continued intervention (maintenance) or a stepped-up condition, while non-responders
will only receive a stepped-up condition. Step-up may include expanded LTI (more text messages) or a high
touch intervention (HTI). The HTI includes text messages and digital resources, including a personalized
survivorship care plan (SCP), on a mobile-friendly platform with information tailored to variables such as
barriers to care, treatment history and recommendations, and a personal health goal. Additionally, social
worker and/or nurse support will be available to help overcome barriers (e.g., access care). The intervention
options in Stage 2 are intended to enhance self-management beyond simply attending LTFU in order to
sustain long-term engagement. Outcomes are measured after Stage 1 (T2), Stage 2 (T3) and at 9 months
(T4). We expect those who start with LTI versus WI will be more likely to attend a LTFU appointment by T4.
For Stage 2, those who receive the stepped-up condition compared to those with maintenance, and those who
received HTI compared to LTI, will be more likely to attend an appointment by T4. Attending an appointment by
T3 and indices of self-management are secondary outcomes. We will also assess moderators of intervention
outcomes, intervention engagement, acceptability, feasibility, and cost. Qualitative interviews will assess
multilevel barriers and facilitators of future implementation with stakeholders (AYA, parents/supports,
providers, administrators). This trial responds to NOT-CA-22-029 and PAR-21-035 to promote optimal
engagement in LTFU and self-management for AYA survivors, improving outcomes and reducing disparities.

Public health relevance
PROJECT NARRATIVE Adolescent and young adult (AYA) survivors of childhood cancer are at risk for second cancers and other chronic health conditions (so-called “late effects”), yet their engagement in long-term follow-up care declines as they transition to adulthood and adult-oriented follow-up care. We aim to fill a significant knowledge gap by testing an adaptive re-engagement intervention specifically targeting AYA who are not currently engaged in follow-up care, and that aims to enhance appointment making, attendance and self-management. The goal is to identify optimal intervention strategies to meet an AYA’s individual needs for re-engagement in care and self-management, ultimately reducing morbidities and health disparities in this population.